The impact of a neonicotinoid pesticide on neural functions underlying learning and memory

Neonicotinoids are pesticides used worldwide and humans are ubiquitously exposed to them.
They are selective for invertebrate nicotinic acetylcholine receptors (nAchRs) with a low affinity
for mammalian ones, a trait that has contributed to their widespread use and assumed safety in
mammals. However, an increasing body of evidence in vertebrates indicates developmental and
adult exposure to neonicotinoids negatively affects a broad range of physiological processes
including immune, reproductive, and metabolic systems. However, relatively little is known about
the mechanisms by which neonicotinoid exposure alters learning and memory or perturbs
neurophysiological signaling pathways. Learning and memory are fundamental cognitive
functions regulated in large part by the hippocampus and striatum of the brain. This is done, in
part, through activation of two forms of nAchRs; α2ß4 and α7. The objective of this proposal is to
test the global hypothesis that neonicotinoid exposure, gestationally or in adulthood, impairs
performance on spatial and procedural memory tasks by perturbing expression of α2ß4 or α7
receptor expression and acetylcholine release. To address this hypothesis, we will treat adult
mice, or pregnant dams, with vehicle, or the environmentally relevant doses of 5.7 mg/kg/day and
0.5 mg/kg/day of imidacloprid. Imidacloprid is the most commonly used neonicotinoid and it has
been detected in samples from children and adults. Adult and gestationally exposed mice will be
tested for spatial memory and reward learning memory (Aim 1). Following behavioral testing,
brains from these animals will be isolated and the protein and mRNA expression of α2ß4 or α7
nAchRs and their subunits will be quantified (Aim 2). Lastly, in adult exposed animals, we will use
a virus-mediated fluorescent acetylcholine sensor and fiber photometry to measure acetylcholine
release targeting the hippocampus while a freely moving animal is engaged in a spatial working
task (Aim 3). We predict males will be more sensitive to neonicotinoids than females and thus
have a significantly disrupted performance on memory tasks and have a larger increase in nAchR
expression in the brain. We also predict that adult exposure will have a larger effect on nAchR
expression compared to gestational exposure. Finally, we predict that imidacloprid exposed
animals will have a reduction in acetylcholine release in response to a memory task. The results
of this novel and comprehensive study will provide a critical identification of possible mechanisms
underlying the impact of neonicotinoids on learning and memory.

Public health relevance
Neonicotinoids are commonly used pesticides and humans are exposed to them daily through food, water, and soil. The proposed research will determine the mechanisms by which prenatal and adult exposure to a neonicotinoid can causes deficits in learning and memory systems in mammals. Identifying how neonicotinoids can act on memory centers in the brain is relevant to public health since it will enable us to improve strategies for prevention or reduction of risks following exposures.